Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
Signaling Aberrations and Cerebral Cavernous Malformation Pathogenesis
The Administrative Core will be responsible for the overall administration of the “Signaling Aberrations and
Cerebral Cavernous Malformation Pathogenesis” Program Project including policy, procedure, and fund
allocation. Specific responsibilities will include oversight and financial management for all projects and cores,
preparation of monthly financial reports, financial forecasting and compliance monitoring, as well as
coordination with the other participating institutions. Additional responsibilities will include managing and
organizing the day-to-day administrative details, teleconferences between the different research groups,
maintaining timelines, and contract/subcontract management.

Public health relevance
NARRATIVE – ADMINSTRATIVE CORE Signaling Aberrations and Cerebral Cavernous Malformation Pathogenesis The Administrative Core plays a critical role in the multi-institutional program of research. The Core staff facilitate and maintain communication among the project members and the NIH, manage research progress and timelines, and manage fiscal and other resources across the sites.